Regulation of Epileptogenesis by Hippocampal Somatostatin Interneurons in a Model of mTORopathies

PROJECT SUMMARY
Over 3.4 million patients in the U.S. have epilepsy, with no preventative treatments and approximately one-
third of patients being refractory to drug treatment. This makes elucidating the basic mechanisms of epilepsy
development a pressing priority so that more effective therapeutics can be developed.
Abnormal excitatory neurons are a common pathological feature of childhood epilepsies, including tuberous
sclerosis complex and focal cortical dysplasia, but it is unclear whether, and which, other cells are responsible
for regulating these neurons. This proposal will address this deficit by evaluating the role of a potentially critical
subpopulation of interneurons. The Danzer lab has developed a mouse model of epilepsy in which Pten, an
mTOR pathway inhibitor, is deleted from a subset of hippocampal granule cells (DGCs) to introduce abnormal
(DGC Pten knockout (KO)) DGCs into an otherwise normal brain. Epilepsy development in these mice
provides evidence of granule cell involvement in epileptogenesis. Although not directly targeted in this model,
animals develop impaired inhibition and interneuron loss. Findings suggest that epilepsy may develop via
accumulation of aberrant DGCs followed by disruption of inhibitory restraint of those abnormal cells.
This proposal will test the hypothesis that somatostatin-expressing (SST) interneurons provide critical inhibitory
control over Pten KO DGCs. A key prediction of this hypothesis is that SST interneuron disruption will
dramatically exacerbate epilepsy severity in these animals. The objective of this research is to evaluate the
significance of hippocampal SST interneurons in the Pten KO model and determine whether ablation of these
sprouted SST neurons induces an increase in disease severity. The hypothesis underlying this proposal is that
SST interneurons restrain hyperexcitable granule cells in the Pten KO model and that loss of these sprouted
SST interneurons will amplify epilepsy severity. To reveal SST interneurons, DGC Pten KO mice that express
a fluorescent reporter in those interneurons have been generated. A viral strategy will be used to induce
expression of a silencing archaerhodopsin in hippocampal SST neurons. Aim 1 will establish whether SST
input to Pten KO cells is enhanced using morphological and patch clamp electrophysiology approaches. Aim 2
will functionally assess the importance of SST neuron-mediated inhibition by determining whether SST
interneuron ablation in Pten KO mice exacerbates their epilepsy phenotype. To evaluate the impact of the loss
of SST interneurons, SST interneurons will be removed either alone or in combination with Pten KO in DGCs
to determine whether interneuron ablation and Pten KO in DGCs will result in more severe epilepsy than either
insult alone. Virally-induced expression of diphtheria toxin receptor in SST interneurons will enable their
ablation after treatment with diphtheria toxin. These studies will reveal how somatostatin interneurons are
altered in the setting of epilepsy and the role they play in restraining mTOR hyperexcitable granule cells.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will increase understanding of the mechanisms of seizure development in childhood epilepsies, including tuberous sclerosis complex and focal cortical dysplasia. Abnormal excitatory neurons in these diseases are thought to play a pro-epileptogenic role in disease progression and exhibit impaired inhibitory input, but it is not clear which cells are critical for effectively inhibiting these hyperexcitable neurons, so this proposal will use a model of focal epilepsy to assess the role of somatostatin interneurons in restraining hyperactive excitatory neurons. Thus, the proposed research is relevant to NIH’s mission to build the knowledge base needed to drive discovery and translation of therapy for epilepsy and will address key goals of the 2021 NINDS Benchmarks for Epilepsy Research, including determining how molecular and cellular function interact with alterations in circuit and network function in the pathogenesis of cortical hyperexcitability and the clinical epilepsies (Benchmark 1c).